Chemosensory Mechanisms Driving Malaria Transmission

To hunt humans and transmit malaria parasites, the African malaria mosquito Anopheles gambiae relies on its
sense of smell to track volatile organic compounds emitted by the human body. Human body odor comprises a
complex blend of hundreds of airborne chemicals derived from our primary metabolism released in skin odor
and breath, as well as secondary metabolites produced by microbial communities living on our skin. Despite
the important role of human body odor in driving malaria transmission, the specific components of human scent
that blend together to modulate this process, as well as the relative contribution of the human skin microbiome
towards human scent chemistry are not well understood. We have recently engineered and validated an
expansive multi-choice system for Anopheles gambiae olfactory preference under naturalistic conditions in
Zambia to rank the attractiveness of whole body scent samples derived from individual sleeping humans to
mosquitoes using infrared motion vision. Leveraging this validated infrastructure and exposure-free assay with
enhanced comparative power, we will recruit a cross-sectional human subjects cohort from the Macha region,
Choma District, Southern Province, Zambia to identify volatile organic compounds in human scent signatures
that are correlated with human attractiveness to Anopheles gambiae at high-resolution. In parallel, we will
perform whole body microbiome profiling using metagenomics to characterize the contribution of the skin
microbiome to human scent signatures. Using this approach, we will identify features of the human microbiome
community and associated microbial metabolic pathways producing volatile organic compounds associated
with modulating human attractiveness to this prolific disease vector. We will also harness conserved
components of whole body odor, along with volatile organic compounds associated with high attractiveness
that we have recently identified using whole body volatilomics, to reverse engineer super attractive synthetic
chemical blends for Anopheles gambiae mimicking the scent signatures of highly attractive humans. These
aims will fundamentally improve our understanding of chemosensory mechanisms modulating olfactory
behavior in Anopheles gambiae that drive malaria transmission and influence heterogeneity in biting risk. From
a translational perspective this research may assist to identify new biomarkers for personal risk of exposure to
mosquito bites and develop novel synthetic formulations of attractants or repellents to combat this primary
malaria vector in sub-Saharan Africa.

Public health relevance
The scent of some humans is more attractive to mosquitoes than others. Such variation in human attractiveness to mosquitoes has important implications for personal risk, including exposure to mosquito bites and the transmission of mosquito-borne diseases such as malaria. A high-resolution understanding of human scent chemistry and the role of the skin microbiome and other biomarkers in modulating human attractiveness to mosquitoes may help to develop new methods to prevent nuisance biting and control mosquito-borne diseases of major public health significance.